Lymphocytes In Autoimmune Lymphoproliferative Syndrome

An extensive flow cytometric evaluation continues of patients with autoimmune lymphoproliferative syndrome (ALPS) and their extended family members, on the basis of characterization of the expanded double-negative T-cell and B-cell populations. Double-negative T-cells have been demonstrated to be alpha beta TcR, CD57+, HLA-DR+, and CD45RA+. This study has been extended to characterize the double-negative T-cells more completely including B220 expression and gamma-delta TcR T-cells in all ALPS patients. In addition, we have initiated expanded characterization of the B cells, directed at memory B cells using CD27 and B220 assessment in these patients. More recently, we have identified a relative deficiency in CD4/CD25 T cells that could be associated with the autoimmunity in this disorder based on recent information identifying this T cell as a critical immunoregulatory T cell. Functional studies directed at this T cell subpopulation will be initiated in the near future.